RESPONSES OF THE VESTIBULOSYMPATHETIC REFLEX IN ENDURANCE TRAINED SUBJECTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The investigators hypothesize that vestibular activation of muscle sympathetic nerve activity will be attenuated after training.